Computational Models for Smart CO2 Monitoring

Project Summary
Among the vital signs of human health, respiratory parameters are key indicators of the physiological status of the
human body. Particularly important to clinicians is the ability to quantify the real-time dynamics and physio-
logical distribution of blood gas measurements of oxygen (O2) and carbon dioxide (CO2), which provide them
with an understanding of the mechanisms associated with both pathological and normal physiological conditions.
The accurate diagnosis of respiratory diseases requires a measure of the partial pressure of arterial oxygen
(PaO2) and the arterial partial pressure of carbon dioxide (PaCO2), called blood gases. The determination of
blood gases requires an arterial blood sample, an invasive and painful process. This procedure, however, pro-
vides only a discrete measurement of respiratory efficacy during a rapidly changing situation. Transcutaneous
monitoring is a noninvasive method of continuously measuring the transcutaneous partial pressures of O2 and
CO2 (PtcO2 and PtcCO2) diffused through the skin, and any changes they undergo correlate closely with
changes in PaO2 and PaCO2. The contemporary methodology for measuring PtcO2 and PtcCO2 requires a
heated sensor and a costly non-portable, bulky, corded sensing unit. The goal of the proposed research is to
develop a computational modeling framework for a miniaturized, noninvasive, wireless, luminescence-
based carbon dioxide sensing wearable device with embedded computational models that can accurately
translate the PtcCO2 to PaO2, a vital clinical parameter.
PIs’ groups recently pioneered a new technique that uses CO2-sensitive luminescence film to monitor PtcCO2.
It requires neither heating nor direct line-of-sight overcoming all the drawbacks of the electrochemical- and IR-
based techniques. Although very promising, PtcCO2’s usage is limited in clinical practice since the previous
studies show unreliable correlation between PaCO2 and PtcCO2 measurements. Our approach will differ from
current practice by predicting the effects of the factors such as temperature, sensor location, age, sex
in order to estimate PaCO2 more accurately. In this research effort, nanoscale bio-electronic components
are tightly integrated with computational models of biological processes for more accurate and personalized
interpretation of measurements in the noisy environment of the human body.
In Specific Aim 1, we will develop computational models of carbon dioxide transport from capillaries through
skin tissue layers using finite element analysis and develop a physics-based estimation algorithm that can be
implemented in a wearable. In Specific Aim 2, we will develop the transcutaneous CO2 wearable with an embed-
ded lightweight estimation algorithm based on computational models developed in Specific Aim 1 to facilitate the
real-time operation of the device. In Specific Aim 3, we will conduct a human pilot study in a lab setting to validate
our proposed monitoring system against the gold standards. Progress on enabling the affordable and scalable
remote monitoring of respiration at home is transformative for medical and scientific research.

Public health relevance
Project Narrative The research objective of this project is to develop a noninvasive, miniaturized, and wearable sensor monitoring carbon dioxide pressure in the blood. Our new technology is proposed as an alternative to the clinical practice of blood withdrawal to measure this parameter informing about the ventilation and respiratory effectiveness of the patient. This new device will allow the monitoring of vital respiration parameters continuously in real-time at home which will revolutionize the monitoring and treatment of numerous respiratory diseases, such as asthma and chronic obstructive pulmonary disease, which are amongst the principal cause of death and illness.